Estrogenic re-mapping of the metabolic response to an energy deficit

PROJECT SUMMARY ABSTRACT
During menopause, estrogen levels decline, and this decline is accompanied by a myriad of metabolic changes,
including decreased energy expenditure. The signaling mechanisms underlying the effects of estrogen on energy
expenditure remain incompletely understood, however. In response to energy deficit, mice have evolved the
ability to drastically reduce their energy expenditure by entering a hypothermic and hypometabolic state known
as torpor. From my preliminary research, it has been shown that circulating estrogens reduce fasting-induced
torpor usage, keeping energy expenditure high even in the face of a dangerous energy deficit. The proposed
research seeks to understand the signaling mechanisms underlying this estrogenic remapping of the metabolic
response to an energy deficit through two major aims. 1) Test whether circulating estrogens reduce torpor usage
by acting on the medial preoptic area of the hypothalamus, a brain region that is sensitive to circulating estrogens
and is known to coordinate torpor in mice, making it an ideal candidate. 2) Test whether circulating estrogens
alter the activity of neurons in the medial preoptic area of the hypothalamus, directly or indirectly, which could
represent a critical cellular mechanism underlying the effects of circulating estrogens on torpor. Together, these
studies will advance our understanding of how estrogen influences metabolic pathways in mice, an important
step towards understanding, and eventually treating, the metabolic changes that occur during menopause.

Public health relevance
PROJECT NARRATIVE Millions of Americans go through menopause every year, yet there remain no safe and effective treatments for the metabolic imbalance experienced by many in the post-menopausal period. This research project aims to test how circulating estrogens, which decrease during menopause, influence energy expenditure in mice via signaling in the brain. Together, the research proposed here will advance our basic understanding of metabolic pathways in mice, an important step towards understanding how these pathways could be manipulated in humans to improve metabolic health post-menopause.